Identifying Inflammatory and Endothelial Mechanisms promoting Cardiac Deformation in Women with a History of Preeclampsia

PROJECT SUMMARY
Women with a history of preeclampsia (preE) are at a 2-fold higher risk of cardiovascular disease and develop
subclinical cardiovascular disease 5 years earlier than women with normotensive pregnancies; however, the
mechanism remains unknown. In our K23 study of 150 participants including 90 with history of preeclampsia and
60 with normotensive pregnancy 2-10 years postpartum, we found evidence of subclinical cardiovascular
disease (myocardial deformation and vascular dysfunction) in those with history of PreE. Our central hypothesis
is that women with a history of preeclampsia will demonstrate long-term elevations in biomarkers of inflammation
and endothelial dysfunction and that these will be directly associated with the observed subclinical cardiovascular
disease. Utilizing the K23 biorepository of 150 samples, we will measure levels of inflammatory cytokines,
endothelial biomarkers and endothelial microvesicles. We will then examine the relationship of these biomarkers
to measurements of myocardial deformation (CMRI) and vascular functional (EndoPAT and SphygmoCor). Upon
completion of these aims, we expect to establish endothelial dysfunction and chronic inflammation as the
mechanisms responsible for the myocardial deformation and vascular dysfunction in women with history of
preeclampsia 2-10 years postpartum. These insights will significantly advance our understanding of these
mechanisms and guide future pharmacological interventions.

Public health relevance
PROJECT NARRATIVE Preeclampsia is a common and serious maternal condition linked to long term adverse maternal cardiac and vascular consequences in women, although the mechanism for these alterations is unclear. The overall goal of this proposal is to determine whether inflammation and endothelial dysfunction are present and associated with myocardial deformation and vascular dysfunction identified through our K23 study in women with history of preeclampsia 2-10 years postpartum. Completion of this proposal will establish endothelial dysfunction and chronic inflammation as the mechanisms responsible for increased risk of long-term maternal cardiovascular disease and provide mechanistic targets for future pharmacological interventions in women with history of preeclampsia.